Protective immunity following dengue virus natural infections and vaccination

Mechanisms of Protective!Immunity after Dengue Natural Infections and Vaccination
OVERALL P01
SUMMARY
The four dengue virus serotypes (DENV1-4) cause the most important mosquito-borne viral disease of humans,
with 100 million cases annually. The mechanisms by which the host immune response to DENV provides either
protection against or enhancement of a subsequent infection with a different DENV serotype are not fully
understood, and this has been a major concern in vaccine development and implementation. The poor results
of the first registered dengue live attenuated vaccine highlight the critical need to better understand the immune
response to natural DENV infections and vaccine candidates and to identify robust correlates of protection. Our
current Program Project has been very successful, generating >50 high-level publications in 3.5 years and
producing key findings that are timely, topical, and impactful. Here, we propose to identify immune
mechanisms responsible for outcomes of DENV infection and vaccination, comprehensively exploring
both the antigenic specificity and Fc functionality of antibodies as well as the quality of T cell responses
in the context of long-term ongoing clinical and epidemiological studies of natural DENV infections and
vaccines. We integrate classical cutting-edge molecular genetic and systems serology approaches to
systematically examine both antigen specificity and Fc characteristics and effector functions of antibodies, as
well as T cell attributes, that predict protection or pathogenesis. We propose a coordinated P01 Program that
includes four projects: 1) Quality of B Cell and Antibody Responses to Natural Dengue Virus Infections; 2)
Dengue Vaccines: Linking Vaccine-Induced Antibody Responses to Protective or Disease-Enhancing Immunity;
3) Quality of T Cell Responses Following Dengue Virus Natural Infections and Live-Attenuated Dengue Virus
Vaccination, and 4) Genetic and Structural Basis for Human Antibody Inhibition of Dengue Viruses. The P01
is highly synergistic in that samples from the same individuals, as well as specific assays, reagents and
methodologies, are shared among the Projects, which are supported by an Administrative Core, Computational
Biology and Statistical Modeling Core, and Clinical and Data Management Core. We will leverage unique
sample sets from the longest continuous cohort study of dengue, in Nicaragua, as well as a cohort study
following recipients of the Dengvaxia® vaccine in the Philippines and human challenge studies of the NIH live
attenuated vaccine. We have have expanded our existing P01 Consortium of world-renowned investigators with
extensive experience and on-going programs in dengue clinical, immunological, and virological research and
vaccine development – thus ensuring a continued high-quality successful research program. All the partners
have a long-standing record of collaboration and numerous joint publications (>225). The Specific Aims
are: 1) Define the antigenic repertoire and Fc characteristics of antibodies that predict outcome of subsequent
DENV infection as well as the long-term humoral immune response; 2) Link vaccine-induced antibody responses
to specific outcomes such as protection, vaccine failure and vaccine-primed severe disease; 3) Demonstrate
that quality of T cell responses influences the clinical outcomes of infection and vaccination and modulates the
quantity and quality of B cell responses; 4) Comprehensively define the protective antigenic landscape of
DENV1-3 type-specific as well as DENV cross-reactive monoclonal and polyclonal antibodies. The
overarching premise is that the accumulation of immunologic data from natural DENV infections, vaccine
cohorts, and human challenge studies, coupled with state-of-the-art computational modeling and data
integration, will enable identification of new immune correlates that predict protective immunity or immune
enhancement, providing critical metrics for evaluating existing and second-generation DENV vaccines.

Public health relevance
NARRATIVE (OVERALL P01) Dengue is a major public health problem worldwide and is complicated by four distinct yet cross-reactive sero- types, such that prior infection with one serotype can either protect or enhance a subsequent infection with a different serotype – posing a major challenge for vaccine development. This Program Project addresses the critical need to improve understanding of the human antibody and B and T cell response to dengue virus infection and vaccination and to identify immune correlates of protection and pathogenesis. To this end, our consortium of world-renowned investigators is applying state-of-the-art immunological methods in the context of long-term ongoing clinical and epidemiological studies of dengue as well as studies of vaccinated populations and human challenge models.